Impact of tissue resident memory T cells on the neuro-immunepathophysiology of anterior eye disease

ABSTRACT
T cells are major clinical targets for anti-inflammatory treatment of persistent ocular pain induced by anterior
eye diseases such as dry eye, yet identification of which T cell subsets drive the pathophysiology of anterior
eye disease remains a topic of intensive preclinical investigation. Emerging data shows that a relatively recently
discovered pro-inflammatory subset of T cells that rarely re-enter circulation dominate the T cell niche on the
ocular surface of humans, but are almost nonexistent in preclinical models of dry eye disease. Establishment
of these tissue resident memory T cells (TRM) in the eye requires pathogen exposure or vaccination, and
because we house laboratory rodents in unnaturally clean environments, they have extremely limited exposure
to pathogens. This lack of immunologic experience has precluded the use of extant rodent models to investigate
the impact of TRM in neuro-immune mechanisms of anterior eye disease, and the potential interaction between
TRM and nociceptors in ocular inflammation and pain remains a pressing gap in knowledge. We propose to
address this gap by infecting mice with a clinically relevant ocular pathogen to establish a population of “human-
like” TRM in the eye that can be specifically targeted for activation or depletion. Using this rodent model, we will
modulate the activity/presence of TRM and/or nociceptors in the anterior eye to test the central hypothesis that
TRM and nociceptors engage in bidirectional neuro-immune interactions that cause ocular pain and
inflammation. These studies will gain critical insights into neuro-immune mechanisms that drive the
pathophysiology of anterior eye disease, and show how prior viral infection shapes the manifestation of
subsequent neuro-inflammation. This work will inform innovative avenues for the treatment of ocular pain and
inflammation, and bear broad impact in the field of neuro-immunology through a first-ever investigation of TRM
interactions with the sensory nervous system.

Public health relevance
PROJECT NARRATIVE Treatment of anterior eye disease is complicated by poorly characterized neuro-inflammatory mechanisms that drive both pain and inflammation. This proposal will address this gap in knowledge by investigating bidirectional interactions between a heretofore underappreciated population of immune cells and pain sensing neurons. This mechanistic analysis in mice will yield data critical to the development of novel treatments for human anterior eye disease.